Reprogramming Macrophages to Improve Vascular Healing in Diabetes

Impaired wound healing in U.S. veterans with diabetes mellitus is a major source of morbidity and mortality as
well as a large financial strain on the VA health care system. Current treatment paradigms, including
debridement of necrotic tissue, infection control, local ulcer care, mechanical off-loading, and management of
blood glucose levels, are modestly effective at best. Despite much research in this area, the critical molecular
mechanisms regulating angiogenesis-directed wound healing remain minimally defined. Recently, our group
identified an important role for inflammatory macrophage VEGF-A production in consequent angiogenesis/
arteriogenesis required for adequate wound healing. Preliminary data support that VEGF-A expression is
increased in “classic inflammatory” macrophages relative to “alternatively activated” or wound healing
macrophages. Our preliminary data also identified that macrophage proangiogenic VEGF-A isoform expression
is dependent on expression of the potent inflammatory cytokine, IL-1β. Animals with macrophage deletion of
IL-1β demonstrated severely impaired macrophage VEGF-A expression and consequent decreases in
angiogenesis and arteriogenesis. We have begun to define a mechanistic pathway, whereby autocrine IL-1β-
IL-1R signaling promotes transcription of proangiogenic VEGF-A, in part, through activation of NF-kB and
STAT3 downstream of the IL-1R. We seek to understand the impact of diabetes on this macrophage
proangiogenic mechanism. Mice with experimental diabetes have profound delays in wound healing in a full
thickness dermal punch biopsy model and perfusion recovery in a hind limb ischemia model of femoral artery
ligation. Isolated macrophages from these diabetic mice demonstrated reduced inflammatory response to IL-1β
via reduced expression of IL-1R signaling complex components along with consequent reductions in VEGF-A
expression, consistent with the macrophage IL-1β-deletion model. The primary hypothesis is that diabetes
mellitus results in reduced macrophage IL-1β-dependent VEGF-A expression with consequent impairment in
angiogenesis-dependent wound healing, consistent with the macrophage IL-1β-deletion model. We seek to 1)
demonstrate disrupted macrophage IL-1β signaling-dependent proangiogenic VEGF-A isoform expression to
be a major mechanism of impaired angiogenesis and wound healing in DM; and 2) validate defective
monocyte/macrophage IL-1R signaling-dependent VEGF-A expression from patients with DM who develop
chronic lower extremity ulcers despite usual standard of care. By defining inflammatory macrophages as key,
early drivers of angiogenesis required for adequate wound healing, our proposed studies support a paradigm
shift away from an anti-inflammatory macrophage strategy being required to activate wound healing, allowing
for macrophage reprograming strategies that promote appropriate activation of inflammatory macrophages
toward consequent angiogenesis-dependent wound healing.

Public health relevance
Diabetes is a common chronic disease in the U.S. veteran population, and non-healing skin wounds are a major cause of loss of limb and debility for veterans with diabetes. Current medical treatments have limited effectiveness at healing wounds because it is not entirely clear how diabetes impairs the healing process. The primary goal of these studies is to identify inflammation signals that direct the early growth of new blood vessels to help with healing. By understanding these mechanisms, we believe these studies will lead to new therapies that promote more effective skin healing and limb salvage for veterans and all patients with diabetes.